Establishing a new genetic mouse model of osteoarthritis

Osteoarthritis (OA) is the major cause of disability among the aging, affecting more than 30 million adults in the US. It is a painful and debilitating disease involving abnormal remodeling of joint tissues. No cure for OA exists and surgical intervention is the only effective therapy. No known treatment prevents initiation or progression of the disease. Lack of understanding of the genes, molecular pathways, and biological processes underlying susceptibility to OA is the key limitation to the development of effective therapies. As noted in the FOA (16- 240) to which this proposal responds: “little is understood about the initial changes triggering disease etiology and early progression.” Our goal is to identify molecular pathways that are vulnerability points for the development of OA: We first discover human gene variants associated with susceptibility to OA and then determine whether and how these gene variants confer susceptibility to OA in genetically modified mouse models. We predict the pathways perturbed by these alleles are pathways whose normal functions guard against OA. We hypothesize these are the pathways that are eroded or compromised during aging. We have identified four families that harbor strongly supported OA-susceptibility variants in genes encoding components of the NOD-RIPK2 signaling pathway. This pathway uses NOD pattern recognition receptors to sense breakdown products and promote inflammatory signaling that directs tissue homeostasis. We propose modulation of NOD-RIPK2 signaling can contribute to OA susceptibility. In this proposal we test whether a rare RIPK2 variant, which segregates with OA and is hyperactive in signaling, affects normal physiology and/or joint maintenance in mice and is sufficient to confer susceptibility to OA in mice. We generated a precisely modified C57Bl/6 mouse that carries the variant protein-coding allele. In two aims we will test if the variant RIPK2104Asp allele: 1) causes an aberrantly prolonged or sustained inflammatory response; 2) alters maintenance of the joint in naturally aging mice; and 3) enhances the onset and/or severity of OA initiated by mechanical injury to the knee joint. The scientific premise for study of the mouse model is strong. The RIPK2 allele segregates as a highly penetrant dominant factor linked to OA and the OA-associated RIPK2 product has increased signaling activity relative to the wildtype protein. Recently we demonstrated the single amino acid substitution has a measurable effect on the immune response of B6 mice. We hypothesize the RIPK2 variant acts as a gain- of-function allele to over-stimulate the inflammatory response to naturally occurring or induced joint damage. Our studies will determine if the RIPK2 allele is sufficient to increase susceptibility to OA in mice, begin to test the link between the NOD-RIPK2 inflammation pathway and OA, and determine types of initiating events that trigger this pathway. Having a mouse model of an allele linked to a common, idiopathic form of OA will allow us in the future to identify i) specific cell types and biological pathways that are key to vulnerability to OA and ii) additional factors that interact with and exacerbate the effect of RIPK2 signaling on OA.

Public health relevance
PROJECT NARRATIVE Osteoarthritis (OA) is a painful and debilitating disease, the major cause of disability among the aged population, affecting more than 30 million adults in the United States. No cure for OA exists, and with the exception of surgical intervention, therapies are solely palliative, failing to prevent the initiation or progression of the disease. This proposal will generate a new mouse model for the study of OA with the aim of discovering molecular pathways that confer susceptibility to OA and that should be targeted in therapies. !